Enhanced injury surveillance using real-time reporting among healthcare workers

Healthcare workers are consistently exposed to hazards with widespread consequences for themselves,
patients, and the organization. In a 2018 Bureau of Labor Statistics report, healthcare continues to have one of
the highest rates of non-fatal occupational injury relative to other industries. Musculoskeletal injuries, violence,
falls, and needle-sticks are most common. It is essential that healthcare systems employ effective and user-
friendly surveillance to allocate resources for injury prevention. However, there is extensive evidence that
reported injury rates significantly underestimate the true risk, and existing injury surveillance systems do not
capture other adverse outcomes that impact health and performance. Other subjective health complains (SHCs),
such as stress and fatigue, are major reasons for sickness and absence from work. Furthermore, near-misses
have long been integrated into injury surveillance of high-risk industries such as aviation, nuclear power, and the
military, but healthcare has yet to systematically assess the incidence of these important sentinel events as part
of injury prevention. Finally, despite federal law and institutional policies promoting employee safety, employees
are reluctant to report injuries due to time constraints, symptom self-management, peer pressure, perceived
`normalcy' of injury, and fear of reprisal. Valid data on the incidence of near-misses, injuries, and time trends are
essential for identifying high-risk areas and deploying resources to mitigate harm. This study will address the
Healthcare & Social Assistance sector and the cross-sector programs of Musculoskeletal Health and Healthy
Work Design & Well-Being by addressing the weaknesses in current injury surveillance methods using a
proactive approach. Our long-term goal is to improve healthcare injury surveillance systems and significantly
reduce work-related injuries. Our specific aims are to: integrate passive injury reporting with active injury
reporting to improve detection of worker harm; leverage unit-based risk metrics, passive and active
injury reports to continuously monitor the work environment; and develop an early-warning system that
will more accurately trigger interventions to decrease the risk of and prevent worker injuries. Randomly
selected patient care providers will verbally record injuries, near-misses, and SHCs on a mobile application for
800 two-week periods. Using advanced statistical methods (e.g. machine learning) and data visualization we will
aggregate injury data and unit-based metrics to produce an injury risk identification and prediction model;
develop a digital heat map to identify high-risk units in near real-time, in a real-world setting, and provide hospital
leaders with notifications with established risk-specific mitigation strategies. We build upon our R21OH010035
project, which established the feasibility of active injury surveillance and documented its superiority to current
surveillance practice. In response to PAR-18-812, our project can shift current practice toward a more rigorous
integration of injury surveillance and prevention.

Public health relevance
NARRATIVE Current ways of collecting employee injuries greatly underestimate the true numbers and risk involved. Our work will improve upon current methods by actively reaching out to healthcare workers to report physical injuries, near-misses, and other health effects by means of a user-friendly mobile application. We will also design a system that will combine information from employee injuries with risk factors from the patient care environment to provide early warnings about high risk areas – leading to improving the health and safety of healthcare workers and can be applied to other industries interested in improving worker safety.